In Vivo Imaging Module

In Vivo Imaging (IVI) Module
Summary
The In Vivo Imaging (IVI) Module is a new module that replaces the previous Multiomics
module. This module addresses increasing requests for instrument adaptations to tailor
technology to specific research needs by our faculty and we anticipate extensive usage by
multiple NEI-funded PIs. The IVI module will support research studies and projects relying on
imaging animal and human subjects. The IVI module provides state-of-the-art instruments for
imaging of the retina, lens, choroid, tumors, microcirculation, tear film and measurement of
mechanical properties of the eye in patients and animal models of ocular disease. Specific Aims
are: 1) To provide cutting edge in vivo imaging capabilities for clinical and basic science
research in patients and animal models of ocular disease using instruments that are beyond
reach of individual laboratories, 2) To provide dedicated personnel for training investigators and
staff on advanced imaging techniques and operating specialized equipment and the associated
analytic tools for in vivo image analyses, 3) To serve as a centralized resource for development
of new instrumentation, adapting existing instruments for new uses and developing custom
algorithms for image analysis. The main goal of the IVI module is that it will formally address
users’ increasing imaging needs under the leadership of a module director and with a dedicated
module manager, which will centralize imaging and analysis expertise to facilitate usage,
maintenance and scheduling, training on and ensuring availability of the instrumentation. The
IVI module will allow expanded application of imaging methods to additional researchers
through collaborations, facilitate new collaborative projects with development of new
instruments and specific adaptations of existing instruments with Department-subsidized
customizing fees, allow more consistent scheduling of the instruments and training, provides
technical expertise for grant proposals, and provides software for image processing and
analysis. Custom-built modifications to imaging instruments will be charged a fee-for-service
that includes components, raw materials, disposable supplies, equipment hire and a composite
engineering fee. The fees will be reduced for NEI R01 holders to support novel research
directions and collaborations by the Dept. Ophthalmology subsidizing 50% of the cost for IVI
(see Chair’s letter). Equipment now consolidated in the IVI module has enhanced collaborations
among NEI-funded investigators and was used to generate data that was reported in numerous
publications and included in new grant awards. The IVI module will be an essential resource
that supports highly innovative research at the forefront of translational research and allows
collaborations among basic scientists and clinical faculty at BPEI, throughout UM and in other
universities in the Miami area.